AUTONOMIC CONTROL OF CARVIOVASCULATURE IN PREGNANCY AND PREECLAMPSIA

We plan to investigate the autonomic control of cardiovasculature changes using power spectral analysis of heart rate and blood pressure variability in five groups of women: 1) non-pregnant, normotensive women; 2) 16-18 week gestation, normotensive pregnant women; 3) 28-32 week gestation, normotensive pregnant women; 4) 37-40 week gestation, normotensive pregnant women; and 5) pre-eclamptic pregnant women at any gestational age.